A 3D vascularized islet biomimetic to model type 1 diabetes

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is an autoimmune disease thought to be caused by immune-mediated destruction of the
insulin-producing β-cells in the pancreatic islets. Studying the mechanisms that underlie β-cell destruction in
humans with T1D has been challenging because most of the important immunological events occur before
diagnosis. Furthermore, while rodent models have been informative in defining some aspects of T1D etiology,
there are fundamental differences between the rodent and human pancreas with respect to islet architecture and
vasculature, as well as between rodent and human immune systems. Additionally, important aspects of human
T1D pathology are not replicated in the rodent models. Therefore, to fully understand human T1D
pathophysiology, it is critical to develop a human model, where the interactions of all cells involved in the disease
process (e.g. β-cells, endothelial cells (EC), innate and adaptive immune cells) can be studied in the context of
normal islet architecture, including vasculature, stromal cells, and native islet matrix. Over the past three years
through the NIH “Consortium on Human Islet Biomimetics”, our team (co-PI Sander: human induced pluripotent
stem cells (hiPSC) and diabetes; co-PI Hughes: vascular biology and bioengineering; co-I Christman
biomaterials and tissue engineering; co-I George microfluidics and transport) has developed a microfluidic-based
platform in which primary human islets or hiPSC-derived islet-like clusters are supported by a network of perfused
human microvessels. Our 3D vascularized islet micro-organ (VMO-I) platform allows for physiologic,
microvessel-mediated delivery of nutrients, disease-relevant stimuli, or immune cells to the islets. We propose
to leverage the unique features of our VMO-I platform to model the cell-cell interactions that occur in the islet
niche during T1D pathogenesis, namely immune cell extravasation, tissue penetration, and migration as well as
β-cell killing. For these studies co-I Teyton will provide expertise in T1D immunology. We propose to employ two
distinct in vitro models: The first, developed in the UG3 phase, is non-autologous and comprised of primary
human islets and vasculature from primary EC. Here, we will introduce either allogeneic lymphocytes (Aim G1)
or islet donor-matched β-cell-reactive T cell clones (Aim G2) to establish parameters for modeling T cell
extravasation and T cell-mediated β-cell killing. We will also work towards the goal of generating a VMO-I model
entirely derived from hiPSC (Aim G3). The second model, developed in the UH3 phase, will be fully autologous,
comprising β-cells, vasculature, and stromal cells derived from T1D patient hiPSC, which will be combined with
autoreactive T cells isolated from blood of the same patient. By combining live-sensors and real-time imaging
with molecular and biochemical assays, we will use these models to study how cells in the islet respond to T1D-
relevant stressors, such as pro-inflammatory cytokines, hyperglycemia, and hypoxia, how immune cells and β-
cells interact, and how β-cells are killed. Finally, we will demonstrate that the platform can be used to assess
candidate therapies for efficacy with the long-term goal to utilize the platform to screen for new therapeutics.

Public health relevance
PROJECT NARRATIVE To fully understand human type 1 diabetes (T1D) pathophysiology, it is critical to develop a human model, where the interactions of all cells involved in the disease process (e.g. β-cells, endothelial cells, innate and adaptive immune cells) can be studied in the context of normal islet architecture, including vasculature, stromal cells and native islet matrix. We will leverage our expertise in creating perfused tissues in culture, hiPSC differentiation, and T1D immunology, to create in vitro models of islet endocrine cells and immune cells in the context of a living dynamic human vascular system and native matrix. We will use these models to study how cells in the islet respond to T1D-relevant stressors, how immune cells and β-cells interact, and how β-cells are killed, as well as test efficacy of the system as a pre-clinical model for drug discovery and testing.